Epigenetic Drivers of Intrinsic Phenotypic Variability in Metabolic Disease

The purpose of this Catalyst project is to apply a highly innovative general theory that integrates evolution,
developmental biology, and epigenetics, to metabolic disease and diabetes. The underling premise is that
intrinsic variability in phenotype from individual to individual, even with an identical genome, is not simply noise,
but is itself in part a signal with adaptive value in evolution, development, and response to the environment.
Moreover, this variability is mediated through the epigenome, has profound effects on metabolism, and is in turn
affected by metabolic signals in the environment during development. If this hypothesis is even in part correct,
the proposed work would provide at least partial solutions to arguably two of the most important problems facing
NIDDK, and NIH as a whole: (1) How can we apply genetic testing, or precision medicine more generally, if the
intrinsic variability from person to person is great, even with ideally complete genetic knowledge? and (2) Is data
irreproducibility in fact driven partly by inherent and adaptive variability that carries information of critical
diagnostic and therapeutic importance? This provocative idea has transformative implications for how we
approach the application of precision medicine to address the growing incidence of obesity and metabolic
syndrome. Existing data using reproducible genomes, such as inbred or F1 hybrid mice, in highly controlled
environments, clearly shows the existing of inherent variability in metabolic phenotypes. To elucidate the
underlying origins of this variability and to develop a paradigm to exploit this knowledge to improve the accuracy
of precision medicine as applied to metabolic disease, we will (1) measure the degree of phenotypic plasticity in
genetically identical mice, testing within-litter inter-mouse variability, inter-litter variability, and inter-strain
variability; (2) determine the effect of prenatal nutritional perturbation on phenotypic and epigenetic plasticity; (3)
translate these findings to assessing the accuracy of human metabolic disease precision medicine; and (4)
investigate sex differences in epigenomic and phenotypic variability. This highly innovative proposal represents
a completely new direction for my research, and could have profound influence on our understanding of the
developmental origins and associated variability in susceptibility to metabolic disease, with profound implications
on future interventions using precision medicine paradigms.

Public health relevance
The purpose of this Catalyst project is to apply a highly innovative general theory that integrates evolution, developmental biology, and epigenetics, to metabolic disease and diabetes. Representing an entirely new area of my research, I will address directly the mechanistic basis for the high degree of variability in metabolism even in genetically identical individuals exposed to the same environment. This highly innovative proposal could have profound influence on our understanding of the developmental origins and associated variability in susceptibility to metabolic disease, with profound implications on future interventions using precision medicine paradigms.